ROLE OF PROSTAGLANDINS IN ANTIHYPERTENSIVE DRUG RESPONSE

Effects of Propranolol, Hydralazine or Hydrocholorothiazide with and without Indomethacin on blood pressure and excretion of 2,3 Dinor--6Keto- PGF 1A, a Prostacyclin metabolite.